A New Model for Elucidating the Genetic Mechanisms of Hybrid Male Sterility in House Mice

PROJECT SUMMARY
A major goal in evolutionary genetics is to identify the genetic variants that give rise to hybrid sterility,
and to understand their mechanisms of action. Hybrid sterility is important because it maintains barriers
between species in nature. The house mouse, Mus musculus, presents a unique opportunity to study
the genetics of hybrid sterility due to the substantial but incomplete reproductive isolation between two
subspecies (M.m.musculus and M.m.domesticus). Male offspring born to a musculus female and a
domesticus male often exhibit hybrid male sterility (HMS). This phenomenon can be replicated
experimentally using inbred mouse strains that are representative of each subspecies.
Two major genetic factors have been shown to cause HMS, but many of the genes involved remain
unknown. We recently identified a specific type of hybrid male that has the known HMS-associated QTL
genotypes, yet is fertile and shows no reproductive impairment. The goals of this exploratory research
project are to identify the genetic variants that rescue fertility in this hybrid, to identify the stage of
spermatogenesis affected by those variants, and to identify the molecular differences between infertile
and fertile hybrid males. These results will advance our understanding of evolutionary genetics,
reproductive biology, and meiosis.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed research explores how genetic variation leads to male infertility in mice. Mice are outstanding models for human biology, and mice exhibiting infertility are good models for human infertility. Many of the genes involved in spermatogenesis and meiosis are shared across the animal kingdom, including mice and humans.